Engineered exosomes carrying synthetic gRNA/Cas9 targeting HBV-infected cells

SUMMARY - Engineered exosomes carrying synthetic gRNA/Cas9 targeting HBV-infected cells
Despite universal vaccinations against hepatitis B virus (HBV), chronic HBV infection remains a public health threat
in the United States and worldwide. The current antiviral treatments, using various nucleos(t)ide analogs (NAs), can
block the HBV life cycle but cannot eliminate integrated HBV DNA and have little effect on HBV covalently closed
circular DNA (cccDNA), which sustains viral replication. Thus, novel curative strategies are urgently needed to
eliminate HBV cccDNA from infected hepatocytes. CRISPR (clustered regularly interspaced short palindromic
repeats)/Cas9 (CRISPR-associated protein 9)-mediated gene-editing is an appealing approach to tackle this
problem. However, the major hurdle in the application of this technology is how to deliver gene-editing drugs to target
cells and elicit specific antiviral activities without causing off-target effects. Notably, the current CRISPR/Cas9
delivery technologies often require viral vectors, which pose safety concerns for therapeutic application in humans.
Synthetic guide RNA (gRNA)/Cas9 ribonucleoproteins (RNPs) represent a novel non-viral formula with excellent
features, including rapid DNA cleavage activity, low off-target effects, no risk of insertional mutagenesis, easy
production, and readiness for clinical use. We have designed and tested a series of gRNA/Cas9 gene-editing RNPs
targeting HBV and selected the most specific and potent gRNA/Cas9 RNP candidates to abolish HBV replication in
HBV cellular models. However, the existing viral and non-viral delivery systems for gRNA/Cas9 RNPs in vivo use
face several challenges, such as non-specific (off-site) delivery, limited drug-loading capacity, low biocompatibility,
poor stability, cytotoxicity, and potential of immunogenicity. These challenges are major bottlenecks, limiting the use
of synthetic gRNA/Cas9 RNPs for in vivo applications. To address these limitations, we developed a novel exosome-
based delivery platform engineered to deliver the HBV gene-editing RNPs specifically to human hepatocytes. These
engineered exosomes are designed in such a way that they carry an HBV pre-S1-derived peptide (binding to HBV
receptor) on the surface of exosomes so that they can more specifically deliver and intracellularly release our
synthetic gRNA/Cas9 RNPs to HBV target cells. In this proposal, we aim to evaluate the capability of these exosome-
based HBV gene-editing gRNA/Cas9 RNPs (herein called Exo-HBV-Eliminator) in targeting HBV-infected
hepatocytes and investigate their antiviral efficacy and potential cytotoxicity using both cellular and animal models.
We hypothesize that our Exo-HBV-Eliminator will specifically target HBV DNA and thus efficiently abolish HBV
replication and elicit minimal cytotoxic effects both in vitro and in vivo. We propose two specific aims to test our
hypothesis. Aim 1 will determine the biophysical and biological properties of our Exo-HBV-Eliminator in vitro. Aim 2
will evaluate the antiviral and off-target effects of our Exo-HBV-Eliminator in HBV-infected, liver-humanized mice in
vivo. The objective of this study is to develop and test a novel gene therapy (engineered exosomes carrying synthetic
gRNA/Cas9 RNPs) targeting HBV cccDNA in HBV-infected hepatocytes that are incurable by the current antiviral
regimens, to lay the foundation for achieving our long-term goal of curing chronic HBV infection.

Public health relevance
NARRATIVE Patients with HBV infection are subject to prolonged (often lifelong) treatment due to the lack of curative therapeutics. Thus, multimodal, robust therapeutic strategies are urgently needed to eliminate HBV cccDNA, which sustains viral replication and is refractory to the current antiviral regimens. Recently, we have designed and selected the most specific and potent gRNA/Cas9 HBV gene-editing drugs using HBV cellular models. We have also developed an exosome-based drug delivery system that can specifically deliver these synthetic gRNA/Cas9 RNP drugs to human hepatocytes. In this proposal, we will evaluate the antiviral efficacy and any potential off-target effects of these dual specific HBV gene-editing drugs, both in vitro and in vivo. The objective of this project is to lay the foundation for future clinical studies to achieve our long-term goal of curing chronic HBV infection. If successful, this novel drug design and delivery platform may be utilized to combat existing and emerging viral diseases. It is thus clinically significant, timely, and relevant to public health.